The SIK2 Inhibitor GRN-300 Enhances PARP Inhibitor Sensitivity and Cytotoxic T-Cell Function in Ovarian Cancer

Ovarian cancer is a significant cause of morbidity and mortality that affects nearly 300,000 women worldwide
each year. Its poor outcomes relate to delayed diagnosis and development of resistance to conventional therapy
with carboplatin and paclitaxel. In the last SPORE cycle, we evaluated a novel inhibitor of salt-induced kinase 2
(SIK2) GRN-300 that enhances sensitivity to both carboplatin and paclitaxel. With the support of the SPORE,
we carried out a first-in-human phase IA/B trial to define the maximum tolerated dose of GRN-300 alone and in
combination with weekly paclitaxel. We also conducted preclinical studies to demonstrate that GRN-300
enhanced olaparib sensitivity in homologous recombination (HR)-proficient and deficient ovarian cancer cell lines
and xenografts. We have demonstrated that GRN-300 enhances olaparib sensitivity by 1) abolishing the class
IIa histone deacetylase 4/5/7-associated transcriptional activity of myocyte enhancer factor 2D (MEF2D), 2)
decreasing MEF2D binding to regulatory regions with high chromatin accessibility in DNA repair genes, and 3)
repressing critical gene expression in the DNA repair pathway. Whereas poly(ADP-ribose) polymerase inhibitors
(PARPi) have played a large part in maintaining progression-free survival in patients with HR-deficient ovarian
cancers, the majority of patients will have resistance to PARPi and experience relapse. Moreover, combining
conventional or other targeted agents with PARPi has been limited by additive myelosuppression. To date, GRN-
300 has had no significant marrow toxicity in our phase I clinical trial. GRN-300 enhanced olaparib activity in
both olaparib-sensitive and acquired olaparib-resistant ovarian cancer cells. Cancer immunotherapy, including
immune checkpoint blockade (ICB), has shown great promise for cancers at multiple sites, but the frequency
and duration of response of ovarian cancer has been limited. Recent studies suggest that a deficiency in DNA
repair is associated with increased response of cancer cells to immunotherapy. We have found that GRN-300
increases phosphorylation of TBK1 and nuclear localization of IRF3 in murine ovarian cancer cells. Both TBK1
and IRF3 are downstream targets of the cGAS/STING pathway. GRN-300 or GRN-300 combined with olaparib
increases the expression of programmed death-ligand 1 (PD-L1) in human and murine ovarian cancer cells.
GRN-300 combined with anti-PD-L1 enhances CD8+ T-cell infiltration and antitumor activity in a syngeneic
ovarian cancer model. The goal of our project is to determine whether GRN-300 overcomes resistance to PARPi
and enhances PARPi sensitivity and whether GRN-300 promotes adaptive T-cell function and enhances immune
checkpoint therapy. We will pursue three aims: 1) to perform a phase IB trial of GRN-300 in combination with a
PARPi, 2) To determine the underlying mechanisms of olaparib resistance that can be overcome with the SIK2
inhibitor GRN-300 in combination with olaparib in ovarian cancer cell lines, xenografts and PDXs, and 3) To
identify the mechanism(s) by which the SIK2 inhibitor GRN-300 sensitizes ovarian cancer cells to ICB and
enhances T-cell cytotoxicity.

Public health relevance
Project 1 NARRATIVE Ovarian cancer is a significant cause of morbidity and mortality that affects nearly 300,000 women worldwide each year, and its poor outcomes are related to delayed diagnosis and development of resistance to conventional therapy with carboplatin, paclitaxel and PARP inhibitors. Inhibition of salt induced kinase 2 (SIK2) has enhanced sensitivity to all three agents. Our proposal will explore the ability of GRN-300, a SIK-2 inhibitor, to enhance response to the PARP inhibitor olaparib and to immune checkpoint blockade, enhancing their antitumor activity.